Heat and Acute Kidney Injury: A Detailed Assessment using Electronic Medical Records and High-Resolution Exposure Modeling

Acute kidney injury (AKI) is a sudden decrease of kidney function that is almost always reversible. While reversible, AKI is serious and often requires hospitalization. The economic burden is also substantial at $5-24 billion annually in the US. Although AKI can arise within already-hospitalized patients (“hospital-acquired AKI”), an unknown proportion of AKI initiates outside of the hospital (“community-acquired AKI”). One potential contributor to community-acquired AKI is exposure to high temperatures, which is thought to impact kidneys largely through volume depletion. Studies using administrative health data have consistently reported positive associations between outdoor heat (high temperatures and heat waves) and emergency department (ED) visits and hospitalizations for AKI. A key limitation of existing studies is the identification of AKI cases through International Classification of Disease (ICD) discharge diagnosis coding. Code-classified AKI, while specific, is not a sensitive marker of AKI; it misses a high percentage of total cases. Moreover, it does not distinguish community-acquired from hospital-acquired AKI, cannot assess AKI severity, and does not provide information on patient context. In addition to these limitations, the majority of population-level studies have relied on spatially crude measures of temperature (e.g., from one or a few monitoring sites) that do not fully capture important urban heat dynamics. This project is motivated by the need for (1) improved outcome assessment, (2) improved exposure assessment, and (3) the identification of heat-vulnerable populations that can be protected via targeted interventions. We will analyze a highly detailed clinical database of over 1.5 million electronic medical records in Atlanta, Georgia for 2013-2021 linked to a high-resolution, state-of-the-art exposure product developed as part of this project. For ascertainment of AKI, we will use ICD diagnosis codes - reflecting the heat-AKI literature – as well as a KDIGO (Kidney Disease Improving Global Initiative)-based serum creatine (SCr) definition comparing ED ‘first-measured’ SCr to baseline values. The KDIGO definition will enable a specific assessment of community-acquired AKI and severity (i.e., stage). In Aim 1, we will develop of a database of ED visits, heat exposure metrics at patient residential address, and individual- and area-level sociodemographic and health risk factors. In Aims 2 and 3, we will estimate associations of short-term outdoor heat exposure and AKI and identify risk factors that increase vulnerability. This work will fill major gaps in the epidemiology of outdoor heat and AKI that will support targeted outreach and education, guide improvements in clinical care, and provide inputs for quantitative risk assessment and economic evaluation of heat-health impacts.

Public health relevance
NARRATIVE Heat exposure is a contributor to dehydration and therefore can affect kidney function. We propose to investigate the relationship between heat (outdoor high temperatures and heat waves) and presentations of acute kidney injury (AKI) at emergency departments in Atlanta, GA. With a focus on improved AKI case ascertainment, heat exposure assessment, and identification of heat-vulnerable populations, this work will fill major gaps in the epidemiology of heat and AKI that will ultimately support public health prevention and clinical case management.